Adaptive Features of In-Utero Natural Killer Cell Responses to Congenital Cytomegalovirus Infection

ABSTRACT
Congenital cytomegalovirus (cCMV) infection is the most common congenital viral infection in the U.S., affecting
approximately 18,500 liveborn infants annually. Children with symptomatic or asymptomatic infection at birth can
suffer from permanent neurodevelopmental disabilities including cerebral palsy, intellectual impairments, visual
deficits, and sensorineural hearing loss. Treatment with the antiviral drug, valganciclovir, improves neurologic
outcomes, but drug adverse effects preclude universal antiviral treatment for all cCMV infected infants. Among
adults with primary CMV infection, natural killer (NK) cells serve as the first antiviral defense and are rapidly
followed by T cell responses that effectively control viral replication. In contrast, cCMV infected infants lack robust
antiviral T cell responses to cCMV infection over the first year after birth. These T cells express an exhausted
phenotype and fail to control viral replication for months to years. In-utero NK cell responses arise during cCMV
infection, but the contribution of these cells to viral control and neurologic outcomes are unstudied. We compared
the NK cell immunophenotypes of cCMV infected and uninfected neonates by CITE-seq and found 4 clusters of
cytotoxic NK cells induced by cCMV infection. These clusters expressed both activating and inhibitory receptors
associated with both NK cells and T cells, and one cluster expressed an inhibitory signature typically observed
during T cell exhaustion. Flow cytometry confirmed that cCMV-induced NK cells expressed inhibitory receptors,
but NK cells of CMV seropositive adults did not. We therefore hypothesize that in-utero CMV infection induces
novel cytotoxic NK cell responses with adaptive-like features that differ from adult responses. We further propose
that cytotoxic NK cell function differs between cCMV infected individuals, is altered by antiviral treatment, and
may correlate with neurologic outcome. In this project we will characterize the adaptive-like features of cCMV-
induced NK cells using blood samples collected longitudinally from a large cohort of cCMV infected infants, CMV
uninfected infants, and CMV seropositive adults. Aim 1 will define the immunophenotype and cytotoxic potential
of NK cells induced by cCMV infection using CITE-seq, spectral flow cytometry, and in-vitro cytotoxicity assays.
Aim 2 will determine the effect of antiviral treatment upon cytotoxic NK cell quantities and immunophenotypes
and explore potential associations between NK cell parameters and cCMV neurologic outcomes. Together,
these studies will elucidate novel features of NK cell responses induced by in-utero viral infection that differ from
adult responses and investigate their relationship to clinical treatments and outcomes among children with
congenital CMV infection.

Public health relevance
NARRATIVE Congenital CMV (cCMV) infection affects 1 in 200 liveborn infants in the United States and can cause permanent neurodevelopmental impairments and sensorineural hearing loss, but robust outcome predictors are lacking. Infants have poor antiviral T cell responses to in-utero CMV infection, but instead generate cytotoxic NK cells expressing adaptive-like features that are phenotypically distinct from adult NK cell responses to CMV infection. This project will investigate the immunophenotype and cytotoxic activity of cCMV-induced NK cells using advanced CITE-seq and spectral flow cytometry methods, determine the impact of antiviral treatment upon these NK cells, and investigate the potential relationship between NK cell immunophenotypes and neurodevelopmental outcomes among a large cohort of cCMV infected infants.